Administrative Core

The Administrative Core of the CIRNA will: (1) monitor and evaluate the progress of the CIRNA, by coordinating the activities of the executive committee and the advisory board; (2) enhance interdisciplinary education of CIRNA trainees and faculty, by coordinating seminars and workshops, and by distributing articles of relevance; (3) enhance interdisciplinary communication among CIRNA investigators and enhance synergy across CIRNA components by coordinating formal and informal meetings among project/core investigators, and maintaining an intranet site and list-serve; (4) facilitate the developmental research program (with the Career Development Core), which solicits and funds promising developmental proposals by trainees and junior faculty; (5) support the CIRNA as a national resource, by providing access to results of CIRNA research and educational information, and by implementing a comprehensive data sharing policy; and (6) provide administrative and budgetary oversight for the CIRNA. Drs. Lerman and Blendy will co-lead the CIRNA and its Administrative Core, with responsibilities based on complementary expertise in preclinical research (Blendy) and clinical research (Lerman).

Public health relevance
The Administrative Core of the CIRNA will provide overall coordination of Center activities to promote cutting-edge science and education, and to facilitate the sharing of information with the scientific community.